Bacterial triggers of neural inflammation.

Project Summary/Abstract
Frontotemporal dementia (FTD) is a progressive neurodegenerative disorder that starts with alterations in
behavior or language and culminates in severe impairment of memory and cognition. While in most cases the
etiology of FTD is unclear, a hexanucleotide repeat expansion in C9ORF72 is the most common inherited cause
of FTD and the related motor neuron disease Amyotrophic lateral sclerosis (ALS). Incomplete penetrance of the
C9ORF72 mutation in families with high prevalence of FTD/ALS indicates that either genetic or environmental
factors modify disease risk. Previously we found that mice with loss of function mutations in C9orf72 experienced
the neural inflammatory features of FTD and died if they were raised in environments that displayed distinct
microbial communities in their gut. Sequencing of fecal matter from environments where C9orf72 mutant mice
displayed divergent health outcomes allowed us to nominate 40 candidate bacterial species that were enriched
in the environments where animals got sick and died. In the first Aim of this proposal, we will use our proxy
macrophage cytokine release assay to determine which of these 40 candidate bacterial species activate an
inflammatory response so that 2-3 bacterial strains can be nominated for functional follow-up. In the second Aim,
we will transplant pro-inflammatory bacteria into germ-free C9orf72 mutant mice to identify strains that trigger
neural inflammation and loss of CNS immune privilege. Our studies will help to identify environmental factors
that credibly contribute to observed heterogeneity in FTD patient phenotype and clinical outcome and provide
insight towards selection of dementia patients most likely to benefit from therapies that target the gut microbiome.

Public health relevance
Project Narrative A mutation in C9ORF72, a gene of poorly defined function, is the most common cause of Frontotemporal dementia and Amyotrophic lateral sclerosis, neurodegenerative disorders that together affect approximately sixty thousand individuals in the United States and approximately 1.4 million people worldwide. This proposal seeks to identify bacteria within the gut that contribute to neural inflammation in mice with a C9ORF72 mutation. New germ-free mouse models generated may be useful to reveal pathways important for neurodegeneration and in the future could serve as screening platforms for candidate dementia therapeutics.